CORE--WHOLE MOUNT IN SITU HYBRIDIZATION

Description: (Taken directly from the application) The aim of this Core is to produce high quality whole mount in situ hybridization for the four projects of this Program. This is a labor intensive specialized procedure, albeit one of great importance to the work of each of the projects. The Core will provide the expertise for achieving high quality results. By utilizing an automated, high throughput system the Core will be able to handle the large number of anticipated samples without delaying any of the research efforts. This support service will free the key personnel on each project from the need to devote time to the labor-intensive manual whole mount in situ hybridization procedure, allowing them to devote their efforts to moving their projects forward.